Regulatory Role of Tandem Tryptophan Codons in Chlamydial Persistence

Project Summary: Regulatory Role of Tandem Trp Codons in Chlamydial Persistence
Chlamydia is an obligate intracellular bacterial pathogen that causes a range of serious diseases in
humans. It is the primary cause of bacterial sexually transmitted infections (STI) and the causative
agent of infectious preventable blindness, trachoma. The major concern of chlamydial infections is that
they are often asymptomatic and undiagnosed, which can lead to chronic sequelae, such as pelvic
inflammatory disease and tubal factor infertility. Consequently, chlamydial diseases remain a significant
burden on health care systems around the world. In adapting to obligate intracellular growth,
Chlamydia has significantly reduced its genome size and eliminated genes from various pathways as it
relies on the host cell for its metabolic needs. Most bacteria respond to amino acid limitation by
engaging a stringent response, which is a transcriptional program used to adapt to nutrient-poor
conditions. The stringent response has also been directly connected with inducing persister cells in
various types of bacteria, which have limited metabolic activity and increased antimicrobial resistance.
Chlamydia can become persistent when limited for nutrients such as tryptophan (trp). They are
morphologically aberrant, display a dysregulated transcriptome, non-replicating, yet remain viable.
Chlamydia lacks the genes necessary to deploy a stringent response, and has very few identified
regulatory elements. How it responds to stress is an intriguing question. We hypothesize that during trp
limitation the decreased translation of key Chlamydia genes with tandem trp codons triggers a
persistent phenotype. The first project goal is to determine how trp limitation impacts the transcriptional
regulation by the iron-dependent YtgR repressor. We will use a combination of next-gen RNA
sequencing, including ChIP-seq, and targeted transcriptional assays to address this. The second
project goal is to determine the mechanism of chlamydial cell division blockage during persistence by
focusing on several cell division genes containing tandem trp codons. A combination of genetic
approaches and morphological studies will be used to determine this. The third project goal is to
monitor host-pathogen interactions, including nutrient acquisition, via cell biological studies. Because
several genes associated with host-pathogen interactions contain tandem trp codons, how the
inclusion interacts with host pathways and organelles is predicted to be altered by trp starvation;
pathways involved in inclusion integrity are maintained whereas those that support chlamydial
progression through the developmental cycle are negatively impacted. The proposal aims to
mechanistically link trp starvation, regulation of translation by tandem trp codon motifs, and
physiological abnormalities linked to persistence. Results will lead to the identification of novel
diagnostic and therapeutic targets that may identify and treat asymptomatic chlamydial infections.

Public health relevance
Project Narrative: Regulatory Role of Tandem Trp Codons in Chlamydial Persistence Chlamydiae are important pathogens of humans and significant causes of morbidity, causing a range of illnesses including sexually transmitted diseases, trachoma, pneumonia, and other respiratory tract infections. The burden of these infections stems from their lack of symptoms, which can lead to chronic conditions such as infertility, reactive arthritis, and pelvic inflammatory disease. The work proposed here will attempt to understand the fundamental processes that allow these asymptomatic organisms to survive and may lead to the identification of novel diagnostic or therapeutic targets that would potentially be able to identify and treat chronic chlamydial diseases.